Dissemination of Data from Randomized Controlled Trials for Demographic Research

Abstract
This project will make available to the research community microdata from two longitudinal randomized control
trials (RCTs) that were implemented to measure the impact of state-sponsored unconditional cash transfer
programs in Zambia. The data sets consist of one baseline wave and multiple post-intervention or follow-up
waves. Multi-topic surveys were administered to households resulting in a range of potential research
questions spanning population and reproductive health and demography. In one of the RCTs, a special survey
was administered directly to adolescents living in the household, covering topics such as mental and physical
health, aspirations, sexual experiences and partner characteristics. This adolescent module further expands
the range of questions that can be addressed to those involving the transition to adulthood. The random
assignment to the cash transfer program allows researchers to examine the causal effect of income support on
health and well-being. This project directly addresses the mission of the Population Dynamics Branch (PDB) of
the NIH to support research in the areas of demography, and reproductive and population health, and the use
of policy experiments. It fits within the PDBs research program on Data Sharing for Demographic Research.

Public health relevance
Project Narrative This project will make publicly available to researchers microdata from two longitudinal randomized control trials that were implemented to measure the impact of unconditional cash transfer programs in Zambia. These data contain information on a range of topics relevant to population health and demography, which, when combined with the randomized control trial, can support research on the role of income in determining health, nutrition, migration, the transition to adulthood and other demographic outcomes in a low-income setting.